Computational Modeling Guided Ablation for Atrial Flutteris

Atypical left atrial flutter (ALAF) is a relatively stable arrhythmia commonly seen in patients after they have
undergone ablation for atrial fibrillation. ALAF can be difficult to rate control and frequently requires another
ablation. These require extensive mapping to delineate the circuit; there may even be undetectable latent
circuits that arise after ablating the dominant one. Mapping is further complicated by very low voltages due to
extensive existing scar, making correct local activation time determination very difficult. At times the only
solution can be treatment by atrio-ventricular (AV) node ablation and pacemaker implant. ALAF is set up
around scar regions in the left atrium. We propose a novel, multidisciplinary approach to managing ALAF in
these difficult cases using personalized computational modeling of atrial flutter to guide ablation. Within our
atrial arrhythmia group, we have pioneered the use of MRI for measuring atrial structure and scar, developed a
wide range of experimental approaches to extend mechanisms of electrophysiology, and applied state-of-the-
art scientific computing, all based on highly integrated local resources. We will apply this multidisciplinary
expertise to improve the understanding and outcomes of post-ablation ALAF. To achieve this goal, we will (1)
use the scar information to make personalized computational models of atrial flutter to identify circuits and
provide guidance to ablation, (2) improve MRI segmentation and thresholding accuracy to determine post-
ablation scar in patients and (3) use the post ablation MRI and outcomes to determine the mechanistic
underpinnings of procedural success and failure in patients who undergo computational model guided ablation
for ALAF at the Salt Lake VA. Left atrial late gadolinium enhancement techniques will be improved to acquire
isotropic images. Machine learning will be used in our extensive database of thousands of left atrial MRIs at
the Salt Lake VA and the Univ of Utah and hundreds of ALAF cases to develop a faster and more accurate
segmentation and thresholding technique. Computational model will be used to carry out virtual
electrophysiology studies to induce flutter with the goal of identifying all the flutter circuits. Further simulations
will be used to test ablation strategies to eliminate all possible left atrial flutters. Our preliminary studies support
these goals by achieving successful prediction of arrhythmias from computational models, at times better than
the most advanced mapping techniques. The result of this project will be a generalized computational model of
ALAF, which can be personalized with left atrial geometry, scar pattern, and mapping results. Such a model
will enable virtual electrophysiology studies leading to the prediction of ablation points to terminate all possible
ALAF pathways. If successful this will lead to improving outcomes, reducing the need for repeat ablations that
have significant cost and risks associated with them and possibly even avoid doing AV node ablations.

Public health relevance
Atypical left atrial flutter seen after ablation for atrial fibrillation can be difficult to treat. Here we are going to develop a generalized computational model, which can be personalized with left atrial geometry, scar pattern, and mapping results. Such a model will enable virtual electrophysiology studies leading to the prediction of ablation points to terminate all possible such flutter pathways.